MRI Study of Normal Brain Development

Four NIH Institutes (NICHD, NIMH, NINDS, and NIDA) jointly sponsored a multicenter study to advance our understanding about how the brain develops in typical, healthy children and adolescents. This study enrolled approximately 500 children, ranging from infancy to young adulthood, who were seen at different time points over a six-year period at several clinical centers around the U.S.. Magnetic Resonance Images (MRI) of the brain were acquired and the imaging findings and standardized neuropsycological tests were administered. In this project we served as a Diffusion Tensor Data Processing Center (DPC). This entailed processing and analyzing all diffusion tensor MRI (DT-MRI or DTI) data that were acquired by the various clinical Centers during the course of the study. Previously, we developed and implemented a DTI data processing pipeline. Specifically we developed procedures for sorting, displaying, and co-registering diffusion weighted images (DWI) from which the DTI data is computed. The image registration procedure accomplishes the tasks of removing the effects of subject motion and eddy current distortion as well as aligning the images to a given template with only one interpolation step, ensuring minimal loss in data quality. We also proposed a new strategy for robust estimation of the diffusion tensor and quantities derived from it. We addressed the task of registering DTI data to other structural MRI data contained in the database using rigid body and linear (affine) transformations. More recently we addressed the task of correcting residual image distortion originating from the Echo-Planar DWI (DW-EPI) acquisition used for DTI. We have developed a DTI processing software (TORTOISE) and have disseminated it to the public through the website https://science.nichd.nih.gov/confluence/display/nihpd/TORTOISE . The software is actively maintained and has an increasing number of registered users. All diffusion data from the Normal Pediatric Brain MRI project have been successfully processed using the TORTOISE pipeline and have been deposited in a database that is accessible by the larger scientific community. We have also produced age-specific brain atlases from these data and we investigated developmental trajectories for several brain regions. The imaging data are now ready for analysis in conjunction with cognitive and other behavioral data available in the database.